Investigating de novo gene evolution in Drosophila melanogaster

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed work seeks to integrate population genomics, transcriptomics, proteomics and genetics to understand the evolution of new genes in natural populations of Drosophila.